Defining the Rules for Pioneer Factor Nucleosome Engagement

DNA binding to chromosomal DNA is essential for many fundamental biological processes
including: transcriptional regulation, DNA replication and repair, recombination, and chromosome
segregation. There is a fundamental gap in understanding how transcription factors (TF) bind
regulatory regions located in compacted, high-order chromatin. Therefore, there is a fundamental
need to determine the mechanistic rules defining TF binding to chromatin. Our long-term goal is
to define the biological rules dictating TF binding to chromosomal DNA in a cell. All TFs, even
pioneer factors, are not able to bind all their targets throughout the genome, indicating that there
are binding constraints imposed on all binding events. Multiple factors appear to impact how TFs
identify TF binding sites (TFBSs) including: TFBS positioning within a nucleosome, TFBS
variants, sequence of the nucleosome, cooperativity, histone modifications, DNA methylation, and
chromatin remodeling. To accomplish our goal, we will combine in vitro with in-cell assays to
allow the systematic dissection of factors required for initial and sustained/functional TF binding
to chromatin. At the nucleosome level, we will use our in vitro Pioneer-seq assay, which allows
the direct comparison of TFBSs located in all possible nucleosome positions, with differing
nucleosome sequences, across many TFBS variants, with modified histones. At the regulatory
region level, we will ectopically express pioneer TFs in comprehensively characterized cell lines,
with cell models of disease, to uncover the chromatin characteristics, chromatin remodelers, or
cooperativity required for TF binding. With this MIRA our lab will close these knowledge gaps by
answering three fundamental questions: 1) How do TFs recognize their binding sites within a
nucleosome? 2) How do histone modifications and nucleosome positioning regulate TF binding?
3) How does chromatin organization regulate TF binding? Our results are expected to have an
important positive impact on our mechanistic understanding of how all TFs regulate transcription
and direct gene expression during normal development and disease. Our findings will likely be
transformative by providing quantitative models for how proteins bind to their targets within or
near nucleosomes.

Public health relevance
Project Narrative The proposed research herein is relevant to public health because defining the mechanisms regulating the essential first step of gene activation—transcription factor binding at cis-regulatory elements—is expected to provide requisite insight into how we may better control normal developmental processes and combat disease manifestation and progression. This research is thus relevant to the NIH’s mission to seek fundamental knowledge about the nature and behavior of living systems.